Skeletal stem cell plasticity in craniofacial bone diseases.

Project Summary / Abstract
Bones in the craniofacial complex are susceptible to various disease conditions due to sustained functional
demand associated with essential activities for survival, such as mastication, respiration, and swallowing.
Craniofacial bones are highly adaptable to external forces, as exemplified by the classical functional matrix
hypothesis; paradoxically, craniofacial bones have limited inherent regeneration potential. While significant
progress has been made in unraveling mechanisms of congenital craniofacial bone deformities, there is a
fundamental gap in knowledge regarding how craniofacial formation is dynamically regulated in response to
incessant functional demand in later life. This gap leads to an insufficient understanding of the mechanisms of
craniofacial bone diseases that clinicians commonly observe in dental practice settings. Dr. Noriaki Ono is an
orthodontist-scientist and a mid-career bone biologist with a steadfast focus on skeletal stem cells and bone
development, with a highly productive research program and a substantial track record of contribution to the
bone research field. The overall vision is to establish a craniofacial bone disease program focusing on
skeletal stem cell plasticity as a central mechanism of craniofacial bone formation in intramembranous
and endochondral pathways. This proposal aims to develop a research program to address fundamental
mechanisms of craniofacial bone diseases from the perspective of skeletal stem cells and their lineage
plasticity. The proposed research program will capitalize on the team's established expertise in mouse genetic
in vivo lineage-tracing approaches and collaborations with single-cell computational biologists. Program 1:
The first program investigates craniofacial skeletal stem cells in the intramembranous pathway. We will
interrogate the fates and functions of periosteal and endosteal stem cells using intersectional genetic
approaches to define how these cells contribute to bone formation in load-bearing craniofacial bones under
normal and regenerative conditions. Program 2: The second program investigates craniofacial chondrocyte
plasticity in the endochondral pathway. We will use high-dimensional single-cell level spatial transcriptomics to
define mechanisms regulating chondrocyte plasticity in the cranial base synchondrosis and mandibular
condylar cartilage. Program 3: The third program capitalizes on two novel craniofacial bone disease models of
idiopathic condylar resorption (endochondral) and osteonecrosis of the jaw (intramembranous) induced by
genetic manipulation in resident stem cell populations. We will delve into in-depth molecular and cellular
mechanisms governing skeletal stem cell plasticity in load-bearing craniofacial bones and how its dysregulation
leads to these disease conditions. The avenue for future clinical translation will be laid with highly collaborative
oral and maxillofacial surgeons at UTHealth Houston. Together, these research programs are expected to
establish skeletal stem cell dysregulation as a fundamental tenet of craniofacial bone diseases, which will
serve as a critical therapeutic target of clinically prevalent conditions in autotherapies.

Public health relevance
Project Narrative The overall vision is to establish a craniofacial bone disease program focusing on skeletal stem cell plasticity as a central mechanism of craniofacial bone formation in intramembranous and endochondral pathways. This proposal aims to develop a research program addressing fundamental mechanisms of craniofacial bone diseases from the perspective of skeletal stem cells and their lineage plasticity. The research program is expected to establish skeletal stem cell dysregulation as a fundamental tenet of craniofacial bone diseases, which will serve as a critical therapeutic target of clinically prevalent conditions in autotherapies.